SACRAMENTO COLLEGE COALITION FOR FUTURE SCIENTISTS

California State University, Sacramento (CSUS) is a comprehensive regional university with a primary emphasis on undergraduate education. This project targets baccalaureate [programs in Biological Sciences, Chemistry, Physics, Psychology and Mathematics. Because of the complementary Missions of the three higher education systems in California, most (70%) of undergraduates at CSUS begin their college education at a two-year community college. The three main campuses (American River College, Cosumnes River College, and Sacramento City College) of the Los Rios Community College District are the Primary feeder colleges for CSUS. This project unites the Campuses of the Los Rios Community College District and CSUS as the Sacramento College Coalition for Future Scientists with the goal of increasing the number of students from underrepresented students who transfer from District colleges to math/science disciplines at CSUS and complete degrees in these disciplines. The project enhances existing interagency transfer projects, and expends and links services provided by existing support programs for the targeted population at each of the participating institutions. To achieve the specified goal, the project includes the following specific objectives: (1) to increase collaboration between CSUS and Los Rios faculties, (2) to increase interactions between Los Rios students in the targeted group and CSUS students and faculty, (3) to enhance academic advising prior to transfer, (4) to improve the academic preparation of Los Rios students in the targeted group, (5) to increase the number of Los Rios students from underrepresented groups transferring to mat/science majors at CSUS. (6) to facilitate transition of student participants to CSUS, and (7) to decrease the time to completion of degree for student participants. To achieve these objectives, the project includes new activities in : articulation and collaborative course development, mentoring and peer networking, academic advising, and academic support.